Youth Empowerment and Safety Intervention for Systems-involved Sexual and Gender Minority Youth at Risk of Suicide

In the general population, suicide is the second-leading cause of death for ages 10 to 24. Child
Welfare (CW) and Juvenile Justice (JJ) involved youth have approximately 3 times greater risk
for suicide ideation, attempts, and completions (i.e., self-injurious thoughts and behaviors –
SITB) than non-systems-involved youth. Sexual and gender minority (SGM) (i.e. lesbian, gay,
bisexual, queer and/or transgender) in the general population have 2-4 times the risk of SITB
compared to their heterosexual, cisgender peers. Notably, SGMY are disproportionately
overrepresented in CW and JJ, with estimates ranging from 16-32% compared to 2-8% in the
general population. In sum, the risk of suicidality for SGMY who are involved with public
systems is markedly compounded; however, the unique needs of this population have been
largely ignored. Few CW or JJ jurisdictions identifying SGMY identities or providing SGM-
affirming care. The proposed quasi-experimental clinical trial study will implement and evaluate
the feasibility, acceptability, and initial impact of Peer Support Specialist (PSS) services for
public system-involved SGMY at risk of suicide. The goal of this study is to evaluate the
feasibility, acceptability, and initial impact of a multi-level intervention, Youth Empowerment &
Safety (YES), comprised of two coordinated components: 1) system-level improved
identification and referral (I/R) of SGMY at-risk for suicide, and 2) introduction of a SGM-
affirming PSS to enhance engagement and support with behavioral health treatment and other
support services. The rationale for the YES intervention is that we will improve outcomes for
SGMY because our SGM-affirming PSS will strategically address modifiable risk factors (e.g.
client-perceived SGM-based provider stigma, mistrust, and internalized queer-phobia) and
protective factors (e.g. peer support, SGM-community connection, self-affirming beliefs, and
hope) for engagement and SITB among SGMY. To do this, we will first develop and implement
standard operating procedures (SOPs) and processes for YES tailored to each setting (JJ &
CBMH). This aim will include a full set of protocols and a training and treatment manual (Aim 1).
We will then evaluate the feasibility, acceptability, and preliminary impact of YES on system-
level targets (Aim 2) and youth-level targets (Aim 3). The proposed research is significant
because embedding PSS in the service continuum where SGMY are overrepresented and
under- or un-identified is a critical systems innovation. YES has the potential to be a low
resource/high impact intervention that could significantly improve service engagement and
equity for systems-involved SGMY. This research is in response to the NIMH call for innovative
systems-based mental health interventions (PAR 121-083) and it is aligned with the NIH-Wide
Minority Health and Health Disparities Strategic Plan 2021-2025. The results of this study will
provide information about if and how affirming identification, referral and connection with an
affirming PSS is feasible, acceptable and impact SGMY identified at risk of suicide. This
information will be used to inform decisions about the need for further research on SGM-
affirming interventions designed to improve the impact of mental health services for this high
risk and overlooked population, with implications for other populations and service settings.

Public health relevance
NARRATIVE The proposed research is relevant to public health as it will help us determine that an affirmative model of identifying, referring, and treating sexual and gender minority youth involved in public systems is feasible, acceptable, and impactful. This timely study will advance a low resource/high impact approach to addressing SITB among public system involved SGMY through the novel use of an affirming Peer Support Specialist embedded in a large community based public health agency. The proposed research is relevant to the NIH’s priority for innovative systems-based mental health interventions (NIMH PAR 121-083) and it is aligned with the NIH-Wide Minority Health and Health Disparities Strategic Plan 2021-2025